A Health Disparities Visualization Tool for Informing Cancer Prevention and Control Efforts

PROJECT SUMMARY/ABSTRACT
The burden of colorectal, cervical, and breast cancer cases and deaths are disproportionately greater among
individuals living in impoverished and underserved areas. Early detection of these cancers through screenings
and timely treatment among individuals diagnosed with precancers or cancers can reduce inequities in these
vulnerable groups. Actionable data to guide outreach efforts, and implement programs and policies are
urgently needed to reduce colorectal, cervical, and breast disparities among low-income and underserved
communities. The National Cancer Institute (NCI) and the American Cancer Society (ACS) recently
emphasized the promise of big data in improving knowledge and providing more accurate data for informing
practice and policies. This project draws from the NCI’s and ACS’s vision of the strategic use of big data and
integrates it within an interactive data visualization framework. We will utilize South Carolina state’s Integrated
Database System (covering health information of over 90% of low-income individuals) to determine colorectal,
cervical, and breast cancer disparities among low-income and underserved individuals and develop a user-
centered cancer disparities visualization tool through stakeholder engagement. Two end products (a web-
based interactive tool and a toolkit) will be disseminated to community organizations and stakeholders working
with low-income and underserved populations. Our goal is to provide useful, usable, understandable health
disparities data and form partnerships with community organizations and stakeholders to implement evidence-
based resources and achieve cancer health equity. Therefore, this proposal is directly responsive to PAR-20-
283 (Objective: Providing health information resources/services to community organizations involved with
health disparity population’). We plan to put the information generated from this study into immediate action by
deploying the Medical University of South Carolina’s fully operational mobile health units to provide cancer
screenings to communities and groups with urgent needs. A data-driven approach to population outreach,
combined with the implementation of evidence-based interventions, could translate into long-term public health
and economic gains.

Public health relevance
PROJECT NARRATIVE This project will develop an interactive web-based tool and a toolkit for community organizations to communicate cancer disparities data in an easy-to-comprehend visual framework. The tool and the toolkit will strengthen cancer outreach efforts, programs, and policies by providing critical insights into unmet needs and inequities among low-income and underserved populations. Our long-term goal is to provide useful, usable, understandable health disparities data and form partnerships with community organizations and stakeholders to implement evidence-based resources and achieve cancer health equity.